GENERAL CLINICAL RESEARCH CENTER

This renewal grant application is requested for continuing support of the existing General Clinical Research Center (GCRC) at the Universtiy of Texas Medical Branch. This GCRC is presently (1980) in its 18th grant-funded year. It is a mixed (adult-child) 8 funded bed unit recently relocated to a modern hospital area on the 6th floor of the Child Health Center. The major clinical research projects presently conducted within the GCRC include studies on sleep apnea, cancer chemotherapy by cancer cell cycle synchronization, hypertension, diabetes mellitus, aplastic anemia, immune deficiency states, lymphocyte depletion in preparation for renal transplantation, gastrointestinal hormone physiology, and malabsorption syndromes in infancy and childhood. Over 40 faculty from both the Basic and Clinical Science Disciplines are involved in these investigations. This federally funded center serves as essential function at UTMB, providing the necessary hospital facility and support personnel to perform such human investigation, and to train future clinical investigators.